LIDOCAINE AND ORAL MEXILETINE SUCCESS IN RX OF VENTRICULAR ARRHYTHMIAS

This study will examine the electrophysiologic and antiarrhythmic concordance of IV lidocaine and PO mexiletine. Ten subjects with organic heart disease and frequent ventricular ectopy will be studied